IL1 as a Driver of Mucosal Immune Dysregulation in Inflammatory Bowel Disease

Project Summary/Abstract
Inflammatory bowel disease (IBD), consisting of Crohn’s disease (CD) and ulcerative colitis (UC), is a chronic
inflammatory condition affecting the human intestine associated with significant morbidity and limited
therapeutic options. Based on the current understanding of IBD pathogenesis, mucosal inflammation seems to
arise from a dysregulated crosstalk between intestinal microbes and poorly understood host immune, genetic,
and environmental factors. Current biologic therapies available for IBD target specific cytokines (e.g. TNF,
IL12/23) or trafficking receptors but a substantial proportion of patients either lose response to, or have disease
refractory to, these therapies. There is an urgent need to improve our understanding of IBD pathogenesis to
fuel the discovery of additional therapeutic targets.
Based on previous investigations, interleukin-1 (IL1) and its associated cytokine family may play a critical role
in IBD pathogenesis. IL10 receptor (IL10R)-deficiency, a monogenic form of CD-like IBD leading to colitis and
perianal disease within the first year of life, is characterized by enhanced IL1 production in macrophages in
both patients and mice. Blockade of IL1 signaling reduces the severity of colitis in IL10R-deficient mice, and
several IL10R-deficient patients have been successfully treated with anti-IL1 therapy as a bridge to curative
stem cell transplantation. Deep mucosal and peripheral immunophenotyping of a large cohort of IBD and non-
IBD subjects using mass cytometry (CyTOF) (Mitsialis et al, Gastroenterology, 2020) has demonstrated that
active IBD, especially CD, is characterized by enhanced IL1 expression in specific myeloid populations.
Although anti-IL1 therapy is not currently used in the treatment of IBD, this data has led to the hypothesis that
there may be subsets of IBD patients with IL1-mediated inflammation, similar to IL10R-deficient patients,
whose disease may be amenable to anti-IL1 therapy.
This project aims test this hypothesis by specifically interrogating IL1-related transcriptomic and proteomic
signatures in IBD. The aims of this project are to (1) define IL1-associated cellular populations in human
intestinal mucosa and blood using single cell analyses (CyTOF and scRNA-seq), and (2) determine how these
IL1-associated populations differ in IBD, non-IBD, and IL10R-deficient subjects, thereby enabling
characterization of IBD phenotypes associated with an enhanced IL1 signature. It is anticipated that IBD
patients with an enhanced IL1 signature may share transcriptomic/proteomic findings with IL10R-deficient
patients and be defined by a common clinical disease phenotype such as stricturing, fistulizing, or otherwise
severe disease. The hope is that the results of this work will guide and set the stage for anti-IL1 therapeutics in
IBD.

Public health relevance
Project Narrative This project seeks to characterize interleukin-1 (IL1)-related inflammatory signatures in the blood and intestinal tissue of patients with inflammatory bowel disease (IBD), interleukin-10 receptor (IL10R) deficiency, and in healthy controls, using a combination of proteomic and transcriptomic single cell approaches. IL10R-deficiency is a monogenic form of very-early-onset IBD characterized by enhanced IL1 expression and can be responsive to IL1 blockade, a treatment relatively unexplored in IBD. A deep understanding of IL1-associated inflammatory signatures in IBD at large will help not only improve our understanding of IBD pathogenesis but identify subsets of patients with enhanced IL1 expression, similar to IL10R-deficiency, who may have disease amenable to treatment with anti-IL1 therapy.